IBUPROFEN ALONE & IN COMBINATION WITH ACETAMINOPHEN FOR FEVER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The investigators hypothesize that combination and alternating regimens of acetaminophen and ibuprofen will be superior to ibuprofen alone for antipyresis in a single six-hour dosing schedule.